RNA associated mechanisms for antigen receptor gene diversification during immature B cell development

PROJECT SUMMARY
Background: VDJ recombination, Class switch recombination (CSR) and somatic hypermutation (SHM) are
three B lymphocyte-specific processes that mediate antibody gene diversification. VDJ recombination requires
the DNA double-strand break generation by the recombination activation genes (RAG1 and RAG2) whereas
CSR and SHM require the single-strand DNA break activity of the activation induced deaminase (AID) enzyme.
Both RAG1/2 and AID activities are coupled with noncoding RNA transcription at sites of DNA break/mutation.
The properties of the ncRNAs generated at sites of programmed DNA breaks are poorly characterized in B-
cells. Recently advances in biology have provided compelling evidence that post-transcriptional and co-
transcriptional regulation of chromatin associated noncoding regulatory RNAs expressed from the IgH
locus (here, nomenclatured as VDJ-carRNA) and their modifications may have significant roles in driving B cell
development and function and prevention of THES immunodeficiency, a severe inherited disorder. In this
application, supported by preliminary data generated in our laboratory, we are evaluating the role of VDJ-
carRNA in early B cell development and VDJ recombination.
Objective/Hypothesis: VDJ-carRNAs expressed from the IgH locus of immature B cells are processed by the
RNA exosome complex to promote VDJ recombination via mechanisms that are relevant for RAG enzyme
activity.
Specific aims: Aim 1: Can B cell development be rescued in exosome deficient mice; Aim 2: Are specific RNA
helicases important for B cell development and VDJ recombination?; Aim 3: Do VDJ-carRNAs influence VDJ
recombination efficiency?
Study Design: Using cell lines and mouse models, we will study potential mechanisms by which RNA
exosome and substrate chromatin associated regulatory ncRNAs (VDJ-carRNA) on the IgH locus play roles in
orchestrating VDJ recombination. We will generate direct evidence that in the absence of RNA exosome and
its essential helicase cofactors B cell development is attenuated due to a direct defect in VDJ recombination.
We will use a combination of various genomic and biochemical tools to elucidate the associated mechanisms.
Disease Relevance: B cells are a central component of the adaptive immune response, but also prone to
undergo leukemias and lymphomas when antibody gene diversification processes are not well controlled.
Moreover, B cells deficient in RNA exosome demonstrate trichohepatoenteric (THES) syndrome, a B cell
immune system disease.

Public health relevance
PROJECT NARRATIVE During B cell development in the bone marrow, rapid transcription at the immunoglobulin loci coding and noncoding segments is essential for the generation of specific antibodies against vast number of antigens. The transcriptional and post transcriptional regulation of the noncoding RNAs generated is important since these ncRNAs not only play an important role in controlling gene expression, genome organization, and DNA rearrangement mechanisms for generating diverse sets of antibodies, but when not controlled properly cause genomic instability and/or B cell immunodeficiency. In this application, we evaluate the role of noncoding RNA expressed from the immunoglobulin loci in developing bone marrow B cells, specifically their role in diversifying the antibody repertoire.